Gait and Clinical Movement Analysis Society 2013 Meeting

DESCRIPTION (provided by applicant): The Gait and Clinical Movement Analysis Society (GCMAS) is an interdisciplinary organization of physicians, physical therapists, engineers, and scientists who develop and use quantitative measurement, modeling, and analysis techniques to study human movement and to design improved treatment strategies for persons with neuromuscular and musculoskeletal disorders. A traditional strength of the society is research aimed at improving ambulation and quality of life for children and adults with neuromuscular disorders such as cerebral palsy, spina bifida, traumatic brain injury, stroke, and spinal cord injury. The 2013 Annual Meeting of the GCMAS, hosted by Cincinnati Children's Hospital, will be held in Cincinnati, Ohio on May 14-17, 2013. This meeting will feature an outstanding scientific program and social events designed to promote cross-disciplinary exchange, including tutorials, keynote lectures, podium presentations, lively poster sessions, and invited case studies. One of the society's important aims is to cultivate the professional development of students at its annual meeting. Indeed, the long-term success of the society depends on the recruitment and nurturing of talented young investigators who will contribute to advances in movement analysis and biomechanical modeling, and who will engage in collaborative, transformative research with members of the clinical community. Funding of this proposal will reduce registration costs and eliminate tutorial fees for students, helping ensure that the meeting is broadly accessible to attendees from diverse backgrounds.

Public health relevance
PUBLIC HEALTH RELEVANCE: The 18th Annual Meeting of the Gait and Clinical Movement Analysis Society will be held May 14-17, 2013 in Cincinnati, Ohio. This meeting will advance clinical treatment of movement abnormalities in individuals with cerebral palsy, stroke, and other neuromuscular disorders by disseminating findings from current research and promoting cross-disciplinary interactions among clinicians, engineers, scientists, and students. This proposal seeks funding to reduce registration costs and eliminate tutorial fees for students, helping ensure that the meeting is broadly accessible to attendees from diverse backgrounds.